Cancer Epidemiology Education in Special Populations (CEESP)

Project Summary: This is a renewal application for years 17-21 of this summer mentored research training
program in cancer epidemiology for U.S. public health graduate students. This application supports a 12-week
mentored summer field research experience in foreign countries and among special populations in the U.S., an
orientation, a career development workshop, and mentored manuscript writing. There are few cancer
epidemiologists who have the skills and experience to implement studies in ethnically diverse settings, whether
in other countries or among migrant and minority populations in this country. Our faculty and field collaborators
have the experience to provide expert field research training and mentorship. An increase in qualified
applications has reduced the acceptance rate from 78% in the first few years to 19%, when the program
became open to students from all 247 U.S. schools and programs of public health in the current funding cycle,
in which students were recruited from 41 states. The program expanded its field research sites in minority
populations in Michigan, Nebraska, and New York. Strong infrastructure in global sites has also been
extended from Africa and the Middle East to Latin America, Asia, and Europe. The publication rate of students
from their summer research data is 78% and alumni published 699 papers after finishing the program. Sixty-
five percent of alumni continued in cancer-related fields.
The objective of this proposal is to continue developing and implementing this summer research program to
prepare graduate students from accredited U.S. schools and programs of public health in the field of cancer
epidemiology in special populations. New features of this renewal application will be increasing the number of
annual positions from 15 to 22 and introducing a workshop for mentors in the beginning of the summer. To
achieve these objectives, the following specific aims are proposed:
1. Recruit and select MPH and PhD students to fill 22 positions each year of the 5-year grant renewal period.
2. Maintain and enhance the infrastructure developed in the past 15 years that supports students in summer
field research experiences in special populations. A new innovation in this renewal will be the development
of a 2-day session for mentors on the subject of mentoring in the beginning of the summer.
3. Maintain and increase the pool of on-campus faculty mentors and field-site research mentors developed in
the past 15 years.
4. Maintain and enhance review and oversight functions of our Research Training Advisory Committee.
5. Maintain and enhance the process of formative and summative outcome evaluation and long-term tracking.
This program will continue to define cancer epidemiology in special populations as a future career discipline for
students in the field of epidemiology. The successful implementation of this program will continue to provide a
source of skilled professionals needed to carry out cancer epidemiology research in special populations.

Public health relevance
This is a renewal application for years 17-21 of this summer research training program in Cancer Epidemiology for public health graduate students. This is a 12-week summer field research experience in foreign countries and among minority populations in the U.S. Our evaluation in the current grant period shows a high level of productivity for our graduates, particularly in their publications and their career directions. The implementation of this program will provide a source of skilled professionals needed to carry out cancer epidemiology research in special populations.